Core-001

The OCTRI Informatics Core has been accelerating clinical and translational research at OHSU, our CTSA Consortium partners, and the broader research community by creating innovative informatics methods, infrastructure, and services since 2006, as a member of the original CTSA cohort. These informatics methods and services cover the translational spectrum from translational bioinformatics, clinical research informatics, and community engagement. With a solid grounding in academic and applied informatics, the OCTRI Informatics Core has provided training to a diverse array of translational workforce members. Building on this prior work, the Informatics Core will further catalyze clinical and translational research through the following aims: Specific Aim 1: Develop and implement novel, targeted informatics approaches to solve translational research bottlenecks and enable new research modalities. Specific Aim 2: Collaborate with other CTSAs as well as other broad-based efforts to improve utilization and extension of data standards, interoperability, and data sharing and security models. Specific Aim 3: Provide training to the translational research workforce in informatics and data science best practices, focused on data and methods dissemination, data re-use, rigor, and reproducibility. A key component of our strategy is to target specific high-impact research bottlenecks through a collaborative, integrative, and multidisciplinary process including scientists, informaticians, IT experts, clinicians, experts in ethics and human subjects protection, community members, and other stakeholders. We will catalyze research by developing and supporting new informatics approaches that integrate the clinical care and research enterprises, and facilitate the recruitment of patients into clinical trials, both regionally and across the CTSA network. We will greatly enrich our already mature data warehouse to incorporate a broader array of data types (e.g., imaging, -omics, social determinants of health) as well as data from our growing partner network. We will leverage OHSU’s investment and commitment to informatics governance, industry partnerships, and human subjects protection expertise to develop innovative, privacy-preserving data sharing methods grounded in informatics concepts and ethical principles. As a leader in training informatics professionals and educating the nation’s workforce in informatics, we will bring new and unique educational opportunities to the nation’s clinical and translational workforce.